The impact of segregation and the mediating effects of vascular risk on 10-year cognitive and functional outcomes in Black/African American older adults enrolled in the ACTIVE study

PROJECT SUMMARY/ABSTRACT
Inequitable social and environmental contexts produced by structural racism and discrimination (SRD) have led
to greater prevalence of Alzheimer’s disease and related dementias, as well as cardiovascular disease, among
Black/African American older adults. The current proposal (1) explores the impact of segregation as a
community-level driver of racial disparities in 10-year cognitive and functional aging trajectories, and (2)
determines if vascular risk partially explains how segregation becomes biologically embedded and ultimately
contributes to adverse aging outcomes among of Black older adults enrolled in Advanced Cognitive Training
for Vital Elderly (ACTIVE) study. The study team builds upon previous census data linkage efforts to improve
estimation of SRD by characterizing multiple indices of segregation (exposures, isolation, clustering); employs
a multi-dimensional research approach by examining social (segregation) and biological (vascular risk) casual
pathways of late-life declines in cognition and everyday functioning; and delineates the effects of segregation
on subjective cognitive concerns, objective neuropsychological performance, and ecologically valid
performance-based measures of everyday functioning. This work meets the direct goals of the NIA’s PAS-19-
391 by specifically clarifying important pathways that create and sustain AD disparities; taking a multi-
dimensional approach to improve the estimation of environmental/built risk factors on longitudinal outcomes;
and leveraging large scale existing datasets to enhance our understanding of factors underlying transitions
from normal to pathological. Findings from this proposal are expected to advance research on modifiable
intervention and prevention pathways that promote more equitable aging outcomes among Black older adults.

Public health relevance
PROJECT NARRATIVE Large-scale longitudinal cohort studies of aging have revealed that Black older adults experience worse cognitive outcomes and accelerated declines in everyday functioning relative to white older adults, although few studies have explored how structural racism and discrimination is a key driver of these disparities. The current proposal integrates community-level measures of segregation into the Advanced Cognitive Training in Vital Elderly (ACTIVE) study in an effort to understand whether segregation (1) is directly associated with 10-year cognitive and everyday functioning outcomes, and (2) works indirectly through vascular health, or biological pathways, to influence these outcomes. Identifying important modifiable sociocontextual and health factors that may create or sustain ADRD is important for targeted prevention and intervention efforts centered on promoting longevity and the maintainance of independence and cognitive functioning amongst Black older adults.